Sustained Attention Neuroimaging in Sleep Apnea

Project Summary/Abstract:
The proposed training grant is designed to advance the academic career of Dr. Ankit Parekh,
PhD, by building on his strong background in applied mathematics (signal and image processing)
and providing multidisciplinary training which will allow him to become an independent quantitative
investigator. Dr. Parekh’s career goals are to enter full-time academic research in sleep medicine
with specialization in developing quantitative biomarkers for daytime sleepiness in obstructive
sleep apnea (OSA). Career development and training: Dr. Parekh’s training plan features an
outstanding research and education environment at the Icahn School of Medicine at Mount Sinai
(ISMMS) along with internationally renowned mentors having complimentary expertise. His
primary mentoring team comprises Drs. Indu Ayappa, PhD, (expert in sleep physiology and
daytime consequences of OSA), David M. Rapoport, MD, (expert in pathophysiology of OSA and
its treatment), Andrew Varga, MD, PhD, (expert in sleep neurobiology, learning and memory) and
Trey Hedden, PhD (expert in neuroimaging). His training plan features a combination of carefully
designed coursework and practical training experiences in 1) experimental design and
methodology, 2) pathophysiology of OSA and sleepiness, and 3) neuroimaging. Research plan:
The proposed research builds on Dr. Parekh’s prior work and pilot feasibility studies funded by
the AASM and ISMMS. The aims of the proposed research are to understand the underlying
causes of inter-individual variability in lapses in vigilance in OSA patients and develop novel
quantitative sleep EEG biomarkers for sleepiness that capture this variability. Using a multimodal
approach involving sleep EEG and daytime fMRI, the proposed research utilizes the CPAP
withdrawal model to show that: 1) Prefrontal and thalamic activity during vigilance testing
mediates the relationship between sleep EEG and next-day lapses in vigilance. 2) OSA is
associated with decreased prefrontal and thalamic activity. 3) Changes in sleep EEG as a result
of OSA will predict the changes in prefrontal and thalamic activity. Successful completion of the
training and research plan will allow Dr. Parekh to contribute independently to research in
development of quantitative biomarkers for daytime sleepiness.

Public health relevance
Project Narrative/Relevance to Public Health: Sleep apnea patients with excessive daytime sleepiness are at highest risk for crashes related to drowsy driving. This proposal aims to identify the brain regions most impacted by sleep apnea and understand the underlying causes of individual differences in impact of sleep apnea. The long-term goal of this K25 is for Dr. Parekh to become an independent quantitative investigator capable of using cutting-edge mathematical tools to develop night-time biomarkers for daytime sleepiness.